Discipline D: Special Project: Analytical Track 2: NFSDX and ORAPP Integration

Hawaii State Department of Health State Laboratories Division Laboratory Preparedness and Response Branch Biological Response Section Discipline D ? Analytical Track 2: NFSDX and ORAPP Integration